Cell-type specific molecular and functional analyses to target dorsal horn pain circuitry in mice and non-human primates

Project Summary
Persistent pain remains a major clinical problem because of its high prevalence and the lack of
adequate treatment options. The spinal dorsal horn is a major site for the integration of
somatosensory information and for circuit-based transformations that underlie persistent pain.
The overall goal our work is to develop novel pain therapies that target the dorsal horn circuitry
for mechanical allodynia. We use cell type-specific targeting of chemogenic receptors to identify
spinal dorsal horn neurons that mediate mechanical allodynia without affecting acute sensation
in mice. Mice are a commonly used model system for these studies because of their general
similarity to humans, the ease of genetic manipulations and the large number of tools available.
However, targeting spinal dorsal horn neurons for therapeutic purposes requires an
understanding of the cellular and molecular conservation between species. Rhesus macaque are
phylogenetically more similar to humans and with re-engineered tools can serve as a proof-of-
principle model system. To this end, we analyzed the molecular and cellular organization of the
macaque dorsal horn by single cell transcriptomics and in situ hybridization methods. We
compared these data to mouse and human data to generate a harmonized atlas of dorsal horn
cell types across species. Here we will 1) Identify the epigenetic landscape of human, macaque
and mouse dorsal horn neurons using single nucleus RNA- and ATAC-Seq data together with
machine learning-assisted bioinformatic approaches to identify regulatory elements (REs) that
drive robust cell type-specific gene expression across species. We will 2) screen candidate REs
for cell-type specificity in mice and subsequently macaque and then use the cell type-specific REs
to systematically generate a functional map of the dorsal horn across species. Studies proposed
here will generate large-scale searchable databases for single cell transcriptomics and open
chromatin regions in mice, macaque and human. Importantly, we will have the knowledge and
viral vectors needed to pursue macaque proof-of-principle studies of novel therapies for
mechanical allodynia.

Public health relevance
Narrative The spinal dorsal horn is a major site for mechanisms that underlie mechanical allodynia after neuropathic, inflammatory and neuropathic injuries. We have generated a harmonized atlas of dorsal horn cell types across species, from mice to human, using single cell transcriptomics. Taking advantage of this atlas and single cell epigenetic data, together with validated machine learning assisted computational analysis, we will identify cell type-specific regulatory elements and then use them to systematically generate an organized functional map of the dorsal horn and to develop cell targeted therapies to treat mechanical allodynia.